Enhancing Surveillance Methods for Genomic Epidemiology in Healthcare

PROJECT SUMMARY/ABSTRACT
This is an application for a K01 award for Dr. Alexander Sundermann, an Assistant Professor of Medicine at the
University of Pittsburgh. Dr. Sundermann aims to become an independent investigator focusing on genomic
epidemiology to prevent healthcare-associated infection (HAI) transmission. This award will facilitate his
development in: (1) advanced genomic and bioinformatics techniques, particularly in bacterial pathogen
genomics; (2) comprehensive biostatistical methods including regression modeling and machine learning on
risks of HAI transmission; and (3) applied healthcare epidemiology, emphasizing the dynamics of pathogen
transmission. To achieve these goals, Dr. Sundermann has created a mentorship team of: Dr. Lee Harrison
(primary mentor), a leader in genomic epidemiology; Dr. Daria Van Tyne (co-mentor), an established genomic
and bioinformatic researcher; and Dr. Graham Snyder (co-mentor), an infectious disease physician and hospital
epidemiologist who utilizes genomic surveillance. Additionally, Dr. Sundermann has also created an advisory
team of experts in statistics, modeling, informatics, and machine learning. Whole genome sequencing (WGS)
surveillance of bacterial pathogens has revealed a large number of previously undetected healthcare outbreaks.
Real-time application of WGS surveillance successfully detects these outbreaks, but interventions to control
them remain unchanged given the unknown of the exact transmission dynamics. Moreover, efforts to control
outbreaks are still reactive for a suspected outbreak rather than proactive prevention. This proposal will test the
hypothesis that the combination of real-time WGS surveillance and targeted environmental cultures will enhance
the identification and control of outbreaks. Additionally, this proposal aims to build an HAI transmission risk
prediction model capable of identifying high-risk transmitters and recipients, allowing for precise interventions to
prevent transmission. The specific aims proposed by Dr. Sundermann will test these hypotheses and create data
for future studies and translational application. In Specific Aim 1, Dr. Sundermann will test the hypothesis that
targeted environmental surveillance cultures will significantly enhance the identification of HAI transmission
pathways and population-level transmission risk compared to real-time WGS of clinical isolates alone. In Specific
Aim 2 he will expand upon a comprehensive risk scoring system for HAI transmission and acquisition to guide
targeted interventions, potentially preventing outbreaks before they begin. The proposed research is impactful
because it addresses the critical challenge of understanding HAI outbreak dynamics, early detection, and
interventions, potentially transforming current reactive approaches into proactive strategies. The proposed
research is also innovative because it leverages a novel combination of real-time WGS surveillance and
environmental culturing to identify and interrupt transmission pathways before outbreaks can escalate. This
interdisciplinary approach blends cutting-edge modeling and bioinformatics with traditional epidemiological
methods, setting a new standard for infection control practices.

Public health relevance
PROJECT NARRATIVE Current methods of detecting healthcare-associated infection (HAI) outbreaks rely on outdated, reactive approaches that are inaccurate and often miss multiple outbreaks. This project will lead to: 1) an enhanced understanding of HAI transmission dynamics within healthcare environments; 2) a comprehensive understanding of the risks of transmission and acquisition of HAIs; and 3) strategies to halt and prevent outbreaks altogether. The application of these findings can result in the reduction of high-morbidity and mortality infections, improving patient safety and providing additional research avenues for future studies on healthcare outbreaks.